Metabolite Profiles Preceding Progression to Diabetes Mellitus after Gestational Diabetes

PROJECT SUMMARY/ABSTRACT
Metabolomics has emerged as a novel approach to identify alterations in metabolites to improve prediction
of type 2 diabetes mellitus (DM) beyond blood glucose. Women with gestational diabetes mellitus (GDM) have
an extremely high rate of conversion to diabetes within 5 to 10 years post-delivery. However, models for
prediction of DM using clinical or metabolic measures are unavailable for this high-risk group. Oral glucose
tolerance testing (OGTT) is recommended at 4 to 12 weeks postpartum, but the OGTT is burdensome for new
mothers and uptake is low. The Study of Women Infant Feeding, and Type 2 Diabetes After GDM (SWIFT)
R01HD050625 (Gunderson PI) enrolled 1,035 women with GDM in 2008 to 2011 and administered 2-hr
75 g research OGTTs and comprehensive assessments from 6-9 weeks postpartum (baseline) and
annually through two years post-delivery. This prospective, well-characterized GDM cohort is uniquely
positioned to address major gaps in our understanding of the pathophysiology and timing of transitions to DM
following GDM pregnancy. Our research team conducted the first study to use a targeted metabolomics
approach to identify and validate a metabolite profile predictive of DM among women with GDM. This study
measured 182 metabolites previously linked with incident DM in adults to identify a metabolite profile consisting
of 4 analyte isotypes [BCAAs, hexoses, PCaeC40:5, SM(OH)C14:1] with predictive ability (83%) that exceeded
fasting glucose alone or 2-hr post-load glucose (72-73%). Although promising, we propose to refine this profile
in the entire cohort, greatly expand the lipid metabolites and test its predictive ability with longer-term follow up.
The overall study goal is to identify a metabolite profile from early postpartum plasma samples that
is highly predictive of incident DM up to 8 years post-delivery in women with GDM. The SWIFT cohort is
exceptional for its racial/ethnic diversity (75% minority), large size, longitudinal Biobank from multiple
research OGTTs and detailed assessments from early through 2 years postpartum with high retention
(83%), and ongoing surveillance via electronic health records (EHR) within a stable membership (84%
remain members 5 years later). The timing is optimal for a 4th in-person research visit at ~8th year post-
baseline to re-assess glucose tolerance and develop prediction tools. The specific aims are: Aim 1. To
identify and refine metabolite profiles at 6-9 weeks postpartum (baseline) that better predict incident diabetes
following GDM pregnancy; we hypothesize that metabolite profiles identified at 6-9 weeks postpartum will be
highly predictive of DM during early (2-year) and later (8-year) follow up periods; Aim 2. To characterize the
metabolic profiles at consecutive time points across follow up (baseline, 1 to 2 years, and 8 years) and
evaluate their relationship to transitions in glucose tolerance; we hypothesize that distinct metabolite profiles
will be strongly related to the stability or deterioration in glucose tolerance over time. An exploratory aim is to
develop distinct metabolite profiles highly predictive of incident DM within specific race/ethnicity groups.

Public health relevance
Project Narrative This study will identify biochemical markers that predict type 2 diabetes mellitus in women after a pregnancy complicated by gestational diabetes mellitus (GDM). Ultimately, the results of this study may lead to improved testing and more effective, personalized interventions to prevent diabetes in women after GDM pregnancy.